Splicing Regulation of Spinal Muscular Atrophy Genes

Summary: Humans have two nearly identical copies of Survival Motor Neuron (SMN) gene, SMN1 and SMN2.
Low SMN levels due to deletion and/or mutation of SMN1 lead to spinal muscular atrophy (SMA), a major
genetic disease associated with infant mortality. SMN2 fails to compensate for the loss of SMN1 due to
skipping of exon 7. Since the full-length mRNAs of both genes code for identical proteins, correction of SMN2
exon 7 splicing provides one of the best therapeutic options. We discovered Intronic Splicing Silencer N1 (ISS-
N1) as a promising therapeutic target for an antisense oligonucleotide (ASO)-mediated correction of SMN2
exon 7 splicing. Nusinersen (SpinrazaTM), an ISS-N1-targeting ASO, was recently approved by the FDA (USA)
as the first drug for the treatment of SMA. While nusinersen has been successful in halting deaths of a vast
majority of SMA infants and slow the disease progression, problems still persist with respect to the speed and
extent of recovery. Hence there is an urgent need to develop alternative and/or complementary mechanism-
based therapies for an improved treatment of SMA. This proposal is aimed at understanding the transcription-
coupled splicing regulation (TCSR) of the SMN genes to uncover novel therapeutic targets for enhancing SMN
levels from SMN2. This project is based on the premise that transcription initiation and elongation regulate both
SMN2 transcripts levels and SMN2 exon 7 splicing. Our proposed study will combine several complementary
and powerful techniques, including native elongating transcription sequencing (NET-seq), precision nuclear
run-on sequencing (PRO-seq), in vivo structure probing and affinity purification of complexes deposited on the
nascent RNAs during transcription by RNA polymerase II (pol II). To ensure the feasibility of our study, we
have generated a SMN2 “super minigene” comprised of the full-length SMN2 promoter, all exons, their flanking
intronic sequences and the 3¢ untranslated region (3¢UTR) of SMN2. We are proposing this study in the light of
a related discovery that SMN genes produce a vast repertoire of circular RNAs (cRNAs or circRNAs). In Aim 1,
we will test the hypothesis that cis-elements within both the promoter and the transcribed region of SMN2
regulate transcription (initiation and elongation) and consequently influence whether exon 7 will be included or
skipped. Employing PRO-seq, we will analyze pol II pause sites during transcription of SMN in different cell
types. We will determine if transcription pause sites are involved in TCSR of SMN2 exon 7. We will assess the
effect of small molecules, including transcription and splicing modulators, on TCSR of SMN2 exon 7. We will
also determine if transcription and splicing modulators affect the generation of SMN cRNAs. We will analyze
tissues from SMA mouse models to determine if cRNAs generated by SMN have relevance to SMA
pathogenesis. Employing a library of SMN2 super minigenes, we will uncover the role of promoter elements in
splicing of SMN2 exon 7. We will also examine if DNA methylation of specific sites within SMN2 has any effect
on TCSR of SMN2 exon 7. In Aim 2, we will test the hypothesis that specific factors that are recruited during
transcription regulate both SMN2 transcript levels and SMN2 exon 7 splicing. Using the SMN2 super minigene,
we will screen for promoter-associated factors involved in TCSR of SMN2 exon 7. We will employ recently
established affinity-based techniques to identify and characterize proteins associated with the transcription
elongation complexes (ECs) recruited at the proximal promoter as well as at the gene body and termination
sites of SMN2. We will analyze ECs by mass spectroscopy. We will validate the role of the identified factors in
TCSR of SMN2 exon 7 by overexpressing and depleting them. We will determine if any of these EC-associated
factors are aberrantly expressed in tissues of mouse models of SMA. We will also examine the role of the
newly identified long non-coding RNAs (IncRNAs) harboring Alu-like sequences in TCSR of SMN2 exon 7. In
Aim 3, we will test the hypothesis that RNA structures is involved in TCSR of SMN2 exon 7. Regions that are
involved in relevant structure formation will be selected based on pol II pause sites identified by PRO-seq data
and on in silico prediction by the Mfold program. We will validate the role of structures in the context of the
SMN2 super minigene. We will confirm the presence of RNA structures by in vivo and in vitro structure probing.
We will test a potential impact of any coordinated interactions between the promoter region and the RNA
structure on TCSR of SMN2 exon 7. We will also examine the potential role of DHX9, an RNA helicase, in
TCSR of SMN2 exon 7 and biogenesis of SMN cRNAs. We will perform a limited study to uncover potential
functions of the top four cRNAs. We will examine if the depletion of these cRNAs has any effect on SMN
transcription, SMN exon 7 splicing and SMN levels.We will also determine the effect of the depletion on the
overall transcriptome and proteome. Findings will reveal novel therapeutic targets for improved and/or
complementary therapies for SMA. Outcome will advance our understanding of SMN2 gene regulation and
identify novel disease modifiers of SMA.

Public health relevance
Project Narrative This proposal is aimed at understanding the molecular mechanism of SMN2 splicing with the goal of uncovering novel regulatory elements that could be exploited for an improved therapy of spinal muscular atrophy (SMA), a leading genetic cause of infant mortality. Proposal has also significance for identifying novel disease modifiers of SMA.